Improving seated postural control and upper extremity function in bilateral CP with a robotic Trunk-Support-Trainer (TruST)

Children with moderate to severe bilateral CP have poor upper extremity abilities and
segmental trunk control deficits. Their independent functional sitting is impaired with decreased
participation in leisure activities, education involvement. Therefore, promoting independent sitting
and improving postural and upper extremity abilities are critical to the health and functional
independence of children with moderate-to-severe bilateral CP (GMFCS III-IV). Despite
significant strides in upper extremity treatments of children with milder (unilateral) CP, there is
limited evidence supporting efficacy of treatments targeting seated postural control in bilateral
CP. Recent robotic equipment allows clinicians to address engagement, repetition, and intensity
to practice task-oriented movements in CP. In this vein, we postulate that robotics can offer a
unique platform to provide efficient motor learning-based training in children with bilateral CP by
implementing postural skill progression. Our team has developed a unique motorized Trunk-
Support-Trainer (TruST) to engage children in play-oriented practice with skill progression. TruST
creates a customized donut-like force field at the region of the torso where balance is lost to
provide active assistance beyond the sitting stability limits through a belt. The training is based
on principles of motor learning, including skill progression.
The overall goal of this work is to develop an evidence-based strategy to promote functional
independent sitting, maximize seated postural and upper extremity abilities, and improve sitting-
related ADLs. Our central hypothesis is that sitting and reaching benefits can be achieved when
a motor learning-based postural intervention is combined with postural-skill progression delivered
via TruST in comparison to a static trunk support. The innovation of this proposal, (RFA-HD-20-
005, ‘Pediatric Rehabilitation’) lies in the fusion of evidence-based clinical practice and novel
robotics with TruST. The result is a training paradigm where children with bilateral CP can receive
motor learning-based postural training in addition to postural skill progression that is tailored to
the child’s postural stability in sitting. If our hypotheses are supported, the TruST-intervention will
be a unique therapeutic solution for children with CP GMFCS III-IV to acquire and improve
independent functional sitting.

Public health relevance
PROJECT NARRATIVE Children with moderate to severe bilateral CP have poor upper extremity abilities and segmental trunk control deficits, limiting independent functional sitting. This study will compare the efficacy of a motorized Trunk-Support- Trainer (TruST) to engage children in play-oriented practice with skill progression with static trunk support . The TruST-intervention will inform clinicians whether such training may be a unique therapeutic solution for children with bilateral CP to acquire and improve independent functional sitting.